Non-invasive brain stimulation using two-coil kTMP: simultaneous stimulation at two cortical targets and deep brain stimulation at a single target

Project Summary/Abstract
Non-invasive brain stimulation (NIBS) offers great potential to treat many brain disorders, and there is
much room for improving methods and, hence, efficacy. A lack of precise spatiotemporal control over
stimulation output combined with insufficient stimulation intensity have limited the ability to effectively
manipulate patterns of brain activity to produce relevant physiological and behavioral change.
Therapeutic efficacy could be significantly improved by targeting brain network activity via stimulation of
multiple cortical sites simultaneously or by targeting single deep brain structures, the latter currently
accessible only through high-risk invasive procedures.
The goal of this proposal is to build upon our innovative one-coil kilohertz Transcranial Magnetic
Perturbation (kTMP) NIBS system by developing a two-coil kTMP system as a response to this urgent
clinical need. kTMP unlocks a previously untapped NIBS domain by delivering high-amplitude, narrow-
band electric field stimuli in the kilohertz range (1-5 kHz) to precisely targeted brain regions. This
advanced system will, for the first time, enable the frequency-specific manipulation of neural activity at
two cortical points simultaneously or within a single subcortical area, achieving stimulation intensities
unattainable with existing methods without discomfort or health risks.
The 6-month funding period will be dedicated to constructing a kTMP amplifier system capable of
independently driving two coils, optimizing induced electric fields for safe and accurate dual-cortical and
subcortical targeting, and implementing a coil navigation system to ensure precise and reliable coil
positioning. If our predictions hold true, a two-coil kTMP system may dramatically enhance the way we
can interact with the brain non-invasively, redefining the treatment space of neurological and psychiatric
disorders.

Public health relevance
Project Narrative Magnetic Tides has developed three generations of a new noninvasive brain stimulation (NIBS) device called kTMP (kilohertz Transcranial Magnetic Perturbation) which operate in a largely unexplored NIBS subspace characterized by high-amplitude, focal, kHz, narrow-band electric field stimuli. This proposal aims to build upon our innovative one-coil kTMP NIBS system by developing a fourth generation kTMP system which employs two induction coils to increase spatiotemporal control of the kTMP stimulus. Immediate applications of a two-coil kTMP system, which could yield more effective therapies for neurological and psychiatric disorders, include (1) independent and simultaneous targeting of two superficial cortical areas, and (2) targeting of a single subcortical area through temporal interference.